Graduate Training Program in Biotechnology

PROJECT SUMMARY
We seek acceptance of our predoctoral biotechnology training program, which has a history of producing
accomplished leaders in academia and industry. Biotechnology is broadening and evolving as a field with an
expansion of knowledge, tools, and applications. In parallel, industry is shaping new efforts using
biotechnology for prevention, diagnosis, and treatment of disease. Stanford provides an unusually rich
environment, with co-located, nationally ranked schools devoted to basic science, engineering, and medicine,
and a strong industrial presence from the surrounding Bay Area. We are leveraging this ecosystem to train
talented students who are becoming the next-generation of interdisciplinary global biotechnology innovators,
and who will lead and invent the future with integrity and rigor. We are seeking training funding for 10 trainees
per year for a period of 5 years. The program fuses 39 investigators from 9 departments across at the university
into a highly visible program that delivers a unique, applications-oriented training experience focused on
health-related biotechnology. Differentiating features of this program include curricular offerings in
biotechnology innovation and leadership, industrial internships, field trips, symposia, and deep interactions
among trainees and academic and industrial mentors.

Public health relevance
Project Narrative This program recruits and trains multidisciplinary predoctoral students to become the next generation of biotechnology leaders and innovators. By integrating rigorous academic research with industry internships and field trips, we equip students with the versatile skills and trainings needed to navigate career transitions and drive impactful improvements in public health.